Characterizing circulating and visceral T cells specific for the autoantigen integrin αvβ6 in ulcerative colitis

PROJECT SUMMARY/ABSTRACT
The integrin heterodimer αvβ6 expressed on intestinal epithelial cells has recently been discovered as the
target of autoantibodies uniquely found in nearly every patient with ulcerative colitis (UC), even years before
disease onset. We propose to find and characterize the T cells ultimately responsible for letting B cells make
these antibodies, and thus reveal a novel insight into how immune self-tolerance to a mucosal autoantigen is
lost in UC, or conversely maintained in people without UC. To this end, we will adapt the Activation Induced
Marker (AIM) assay that we have used extensively in the study of type 1 diabetes to now evaluate UC. This will
allow us for the first time to employ this assay on cells from the mesenteric lymph nodes of humans, where
much of the T cell-B cell interactions necessary for gut-centric antibody production occur, and leverage data
thus generated into an analysis of the colonic mucosa itself. We are able to do this because we uniquely have
a bank of cryopreserved live MLN and colon samples from the surgical resections of dozens of people with UC
and Crohn's disease, in addition to cryopreserved live blood cells and serum from hundreds of other UC
patients and healthy controls. The AIM assay is designed to independently evaluate pro-inflammatory and
regulatory T cells. In addition to finding and immunophenotyping autoantigen-specific T cells by flow cytometry,
the AIM assay will allow us to isolate these cells for single-cell analyses of their gene expression profiles and
unique T cell receptor sequences. These in turn serve as a unique identifier with which to track autoantigen-
specific T cells throughout the body, including in the colon, where autoreactive T cells may play a direct role in
promoting or suppressing pathology.

Public health relevance
PROJECT NARRATIVE People with the chronic inflammatory bowel disease ulcerative colitis (UC) were recently found to uniquely make antibodies to a complexed pair of proteins (integrins αv and β6) on the epithelial cells that line their intestines, even years before diagnosis. We have experience with an assay that will let us find the T cells behind these antibodies in the blood, colons, and lymph nodes we have archived from people with and without UC. T cells govern immune memory and tolerance, so by deeply characterizing these T cells in UC and comparing them to similar cells from people without UC, we shall learn fundamental truths about how the intestinal immune system is regulated in humans.